Applications of Trajectory and Transition Modeling Methods to Characterize the Dynamic Relationship Between Food Insecurity, Health, and Health Care Use in Low-Income Older Adults in the United States

PROJECT SUMMARY
Food insecurity is an unmet social need associated with poorer health and higher mortality, morbidity, health
care use, and health care expenditures. Among older adults in the U.S., food insecurity is of particular concern
due to its recent rise in prevalence and its association with barriers to healthy aging such as nutrient
deficiencies, multiple chronic conditions, functional limitations, falls, and cognitive decline. The growing number
of food-insecure older adults places additional demands on health care delivery systems to provide
coordinated and whole-person care that effectively and efficiently responds to the medical needs of older
adults and their social context. To achieve this, providers need rigorous, longitudinal evidence addressing the
short- and long-term impacts of food insecurity on older adults’ health care needs, the health and health care
consequences of fluctuations in food insecurity over time, and the influence of health care use and patient
characteristics on future food insecurity risk. Although research on food insecurity and health is growing, the
vast majority of studies use cross-sectional designs or short follow-up periods and do not capture the transient
nature of food insecurity, nor the cyclical and mutually reinforcing relationship it has with health and health care
use. Moreover, there is scant evidence on longitudinal patterns of food insecurity and transitions into and out of
food insecurity in older adults, and although food insecurity is more prevalent among several racial and ethnic
minority groups, little is known about differences in the influence of food insecurity on health care outcomes
across these groups. As a result, providers and health systems have limited knowledge of when, how, and for
whom food insecurity results in changes in health and health care needs. To address these knowledge gaps,
the proposed study will leverage five waves of the Health and Retirement Study, a nationally representative
longitudinal survey of community-dwelling older adults ages 50 and over, to characterize how changes in food
insecurity and health care needs influence each other as individuals age and examine how these relationships
vary across racial and ethnic groups. To achieve these goals, the project aims to (1) compare associations
between food insecurity and changes in health and health care outcomes among white, non-Hispanic Black,
and Hispanic older adults (2) identify sub-groups of low-income older adults who follow different food insecurity
trajectories and the health and health care outcomes associated with each trajectory; and (3) estimate the
probabilities of becoming, staying, or ceasing to be food insecure among low-income adults with different
racial/ethnic identities, demographic and socioeconomic characteristics, health needs, and health care
experiences. This study will employ novel applications of trajectory and transition modeling methods to improve
foundational knowledge on the longitudinal relationship between food insecurity and health care use in order to
inform improvements in the capacity of health care delivery systems to identify, anticipate, and intervene on the
health care needs of food-insecure older adults.

Public health relevance
PROJECT NARRATIVE Food insecurity among older adults is associated with greater mortality, morbidity, health care use, and health care expenditures, and is becoming a growing concern due to its rise in prevalence over the last two decades. Longitudinal evidence characterizing the dynamic relationship between food insecurity and health care needs as individuals age is lacking, including how the influence of food insecurity varies across racial and ethnic groups. Modeling food insecurity and health care trajectories and transitions in older adults with different racial and ethnic identities will improve understanding of when and for whom fluctuations in food insecurity and health care needs influence one another and inform the development of health care delivery strategies that can more effectively anticipate and manage the medical and social needs of older adults.